Strengthening Parenting, Young Children's Social-Behavioral Competence, and Kindergarten Readiness in Schools Serving Low-Income Communities

ABSTRACT
Social, emotional, and behavioral (SEB) problems are among the most common chronic disabilities affecting
children growing up in urban and rural poverty. They also have implications for children’s school success as
they affect essential social-emotional learning skills such as the ability to comply with rules, follow instructions,
regulate emotions, and get along with others. These essential skills are first learned before kindergarten (K)
entry, in the context of a supportive, responsive, and consistent parenting relationship. To date, universal
school-based interventions to improve young children’s social-emotional learning have primarily targeted
students and teachers. Yet, parents are the central figures in young children’s lives and they need to be equal
partners with schools in promoting SEB skills. This study seeks to improve children’s SEB competence and K
readiness by strengthening parent engagement and parenting skills in early childhood education during
prekindergarten (PreK). This hybrid Type 2 effectiveness-implementation trial will rigorously evaluate the
effects of an evidence-based parenting program, called the Chicago Parent Program (CPP), implemented in
PreK on K outcomes in urban and rural Title 1 schools in Maryland. Effectiveness Aims: Using a cluster
randomized design (N=30 schools, 840 families; >90% low-income), we will examine the effects of CPP
offered universally to Title 1 PreK parents on a) children’s SEB competence, parent engagement, and
parenting skills; and b) K readiness, chronic absence, and grade retention in K. We will also examine the
mechanisms underlying those effects. Schools will be stratified by rural vs urban district then randomized to
experimental (CPP) or control (usual practice) conditions. Data will be collected from multiple informants
(parents, teachers, CPP group leaders, school personnel, district administrative data). Implementation Aim:
Using the RE-AIM framework and a mixed methods approach, we will assess CPP reach, effectiveness,
acceptability, adoption, implementation, cost-effectiveness, and sustainability when offered in different formats
(virtual CPP groups vs in-person CPP groups) and contexts (urban vs rural schools). Schools will participate
for 2 years with experimental schools offering CPP twice, once in a virtual group format and once in an in-
person group format (format counterbalanced), giving us the ability to compare a range of outcomes
associated with uptake, acceptability, cost, and sustainability by CPP format in low-resource rural and urban
contexts. This study addresses the NICHD priority to test developmentally informed interventions designed to
ameliorate early adverse environmental effects on children and optimize their growth, development, and SEB
wellbeing. Children’s SEB health and school success are inextricably linked and both are adversely affected by
racial and economic inequities that have been exacerbated by the COVID-19 pandemic, heightening the
urgency of this research for supporting children, families, and schools.

Public health relevance
PROJECT NARRATIVE Young children’s social-emotional-behavioral health and school success are inextricably linked, and both have been adversely affected by racial and economic inequities exacerbated by the COVID-19 pandemic. This study will 1) test the effects of a universal group-based parenting intervention in prekindergarten on a range of parent, child, and school outcomes associated with children’s wellbeing and later academic success and 2) evaluate its cost, acceptability, implementation, and sustainability when offered in different formats (virtual vs in-person) in urban and rural public schools serving low-income students. This study seeks to improve children’s social-emotional-behavioral wellbeing, kindergarten readiness skills, and school outcomes by building on parents’ strengths and promoting engagement in their children’s education during the early years.